Tumor-selective use of PARP inhibitors against NQO1+ nonsmall cell lung cancer

Our long-term goal is to develop novel antitumor therapies to treat recalcitrant non-small cell lung cancers
(NSCLCs) by exploiting their unique over-expression of the two-electron, Phase II detoxifying enzyme,
NAD(P)H:Quinone Oxidoreductase 1 (NQO1) in combination with inhibitors of poly(ADP-ribose)
polymerase inhibitors. In NSCLC, NQO1 is elevated 5- to 200-fold above associated normal tissues,
while catalase levels are expressed at extremely lower levels in NSCLCs than in associated normal lung
(or all other normal) tissue. We showed that unique and novel NQO1 bioactivatable drugs, (e.g., ß-
lapachone (ARQ761 in clinical trials), are `bioactivated' by NQO1, resulting in massive H2O2-induced,
apyrimidinic/apurinic (AP) site- and DNA single-strand break-mediated hyperactivation of poly(ADP-
ribosyl) polymerase 1 (PARP1) that causes dramatic NAD+ losses (Huang et al., Cancer Res, 2012).
However, co-administration of a PARP inhibitor dramatically enhances the antitumor activities of these
drugs (Huang et al., Cancer Cell, 2016). We have discovered a much more potent NQO1 bioactivatable
drug, isobutyldeoxynyboquinone (IB-DNQ) that is significantly more synergistic with PARP inhibition that
ß-lapachone. We hypothesize that IB-DNQ will be a significantly better drug alone than ARQ761 (ß-
lapachone) and result in significantly greater synergistic, NQO1-dependent antitumor activity in
combination with PARP inhibitors against NQO1+ NSCLC cells. We propose to complete three specific
aims to test this hypothesis.: Aim 1: To define the mechanism of action of PARP inhibition + IB-DNQ
synergistic cell death (Yrs 0-5); Aim 2: To define the role of IB-DNQ-induced H2O2-related
bystander effect in simultaneous NQO1+ programmed necrosis vs NQO1- apoptosis in matched
NSCLC cells (Yrs 0-5); and Aim 3: To define the tumor-selective, NQO1+-dependent antitumor
effects of the PARP inhibition + IB-DNQ regimen vs IB-DNQ alone in orthotopic NSCLC xenografts
(Yrs 0-5). The aims will be performed using genetically matched NQO1+ vs NQO1- NSCLC cell lines by
si/shRNA knockdown of NQO1+ human cancer cell lines and/or forced NQO1 over-expression to match
known levels in polymorphic NQO1- human NSCLCs. We will also examine genetically match PARP1
si/shRNA knockdown vs normal NSCLC cells in vitro and in vivo.
We assembled an outstanding research team to explore the metabolic, bystander, and efficacy effects of
PARP inhibition + IB-DNQ treatments in orthotopic NSCLC xenograft models in this 5-yr grant. Our
results should lead to the development of a clinical trial using this combination in 5 years.

Public health relevance
Nonsmall cell lung cancers have inherent cancer vulnerabilities, such as the need to over-express specific enzymes, such as NAD(P)H:quinone Oxidoreductase 1 (NQO1), for their survival. We are developing tumor-selective therapies using unique compounds that are over-metabolized by NQO1 in a manner that ultimately kills lung cancers (specifically NSCLC), but have no effects on normal tissue. We will develop cancer- selective strategies of therapy using a unique drug, isobutyldeoxynyboquinone (IB- DNQ), in combination with inhibitors of the DNA repair enzyme, poly(ADP-ribose) polymerase (PARP) for a clinical trial within 5 years.